Development of genetic tools for the study of mosquito hemocytes

PROJECT SUMMARY
Mosquitoes have developed a robust innate immune system comprised of cellular and humoral immune
responses that together shape mosquito vector competence, which as a result has garnered significant interest
as potential targets to make mosquitoes refractory to disease transmission. Immune cells, known as hemocytes,
are central to mosquito cellular and humoral immune responses that include phagocytosis, the establishment of
immune memory, and the recognition and killing of malaria parasites. Yet, despite their importance, studies of
mosquito hemocytes have been limited by a lack of genetic resources that have limited their characterization to
morphological properties of size and shape. With a long-term goal to characterize mosquito immune cell
populations and their contributions to innate immunity, the overall objective of this application is to develop
genetic tools and resources to improve our understanding of mosquito immune cell function. Recent single-cell
studies have characterized mosquito immune cell populations with new and increased resolution, providing the
identification of candidate universal or subtype-specific marker genes that define immune cell sub-populations.
Serving as the foundation and rationale of this proposal, regulatory regions of these candidate hemocyte
marker genes will be used to generate transgenic Anopheles mosquitoes that drive fluorescent markers (Aim 1)
or transcriptional activators (Aim 2) in distinct immune cell populations. Together, our proposed experiments will
provide valuable new genetic resources for the mosquito hemocyte community that will significantly advance our
understanding of Anopheles immune cell biology, while serving as the foundation for future studies to better
define the contributions of hemocytes to malaria parasite killing.

Public health relevance
PROJECT NARRATIVE The mosquito innate immune system is central to defining whether mosquitoes can transmit various mosquito- borne pathogens that collectively cause more than 300 million human cases every year. This includes essential roles of mosquito immune cells, or hemocytes, that mediate cellular and humoral immune responses that promote the recognition and killing of mosquito-borne pathogens. However, efforts to study mosquito hemocytes have been severely limited by the lack of genetic tools. To better understand hemocyte contributions to the mosquito immune system, we will develop transgenic immune cell markers and genetic resources to significantly advance our understanding of how mosquito immune cells limit malaria parasites in the vector host. The resulting information and its application towards strategies to interrupt malaria transmission in the mosquito vector are relevant to the mission of NIH-NIAID supporting basic research to understand and prevent human disease.